Mentoring and Research in Patient-Oriented Geriatric Emergency Care

PROJECT SUMMARY / ABSTRACT This proposed K24 combines mentoring to train the next generation of patient-­oriented investigators in geriatric emergency care research, career development in mentoring and implementation science, and research to translate the innovative model of community paramedicine to practice, thereby providing support to community-­dwelling patients with Alzheimer’s Disease (AD) and their caregivers. The PI, Dr. Manish Shah, is a leading geriatric emergency care researcher with a record of developing and testing novel models of community-­based care to improve the health of acutely ill older adults. His work has enhanced acute illness care for older adults as well as identifying and addressing older adults’ medical and psychosocial needs using community-­based paramedics, a model now called “community paramedicine.” The next step of this work, reflected in the scientific aims of this proposal, is to refine the community paramedicine model of care to support community-­dwelling patients with AD and their caregivers, among the most vulnerable older adult populations. This work will build on his NIA-­funded R01 testing the effectiveness of paramedics to support care transitions and decrease emergency department (ED) visits through motivational interviewing, coaching, education, and in-­home care. Using the Replicating Effective Programs and RE-­AIM frameworks, he will refine, implement, and pilot test a specific community paramedicine program for patients with AD that includes similar interventions to prevent ED visits and deliver acute illness care in patients’ homes. Dr. Shah is also a sought after mentor for developing researchers. He will use this award to build a robust pipeline of aging researchers focused on improving acute illness care for vulnerable older adults. This proposal takes advantage of exceptional resources at UW, including the successful CTSA, which is committed to mentoring, team science, implementation science, the KL-­2 program (Dr. Shah is Assistant Director), numerous potential mentees, and one of the leading aging research programs. This award would provide the release time to build the formal mentoring program and mentor an initial cohort of patient-­oriented researchers. Upon completion of this award, Dr. Shah will have developed a robust platform to mentor a diverse pool of patient-­oriented researchers, acquired additional knowledge and skills to expand his research to patients with AD, and helped advance research in the emerging field of geriatric emergency medicine. Finally, he will be well-­positioned to compete for new R01-­level awards to perform hybrid effectiveness-­implementation studies to definitively test this application of community paramedicine for older adults with AD.

Public health relevance
PROJECT NARRATIVE The emergency department (ED) is a common source of acute illness care for older adults, particularly the most vulnerable individuals such as those with Alzheimer’s Disease or with barriers to accessing primary care. Unfortunately, evidence suggests that up to 25% of visits could be prevented and the ED is a suboptimal place for older adults to obtain care for minor illnesses. Through this award, Dr. Shah proposes to enhance his research and mentoring skills and leverage extensive University of Wisconsin resources to: 1) develop a robust platform to mentor a diverse pool of patient- oriented, geriatric emergency care researchers and 2) use the principles of implementation science to refine and pilot test the community paramedicine model of care to benefit community- dwelling older adults with Alzheimer’s Disease and their caregivers.